Cellular, Biochemical and Molecular Sciences Training Program

The experimental toolkit available to contemporary scientists is extraordinary, permitting rapid
experimentation with previously unknown precision and innovation. In essence, however, the principles that
underlie scientific inquiry remain unchanged. Our PhD training program in Cellular, Biochemical and Molecular
Sciences seeks to blend these foundational principles with state-of-the-art research and the opportunity to
develop a breadth of skills and explore a diversity of career options. We will select 6 trainees from the cohort of
students who enter our PhD program through a common portal, and will support them during their 1st and 2nd
years (in total, 12 trainees/year). Our 49 training faculty, representing multiple departments and disciplines, are
part of a cohesive scientific community that offers a strong mentoring environment.
Central to our new training program is the commitment to educate a diverse population of students to
conduct science in a rigorous, reproducible, creative and ethical manner. Our curriculum will emphasize the
ability to think critically, to build and test models and hypotheses, and to understand the essential principles of
experimental design. Biomedical science is an empirical discipline, and our students must understand the
strengths and limitations of contemporary and classical methodologies. The ability to critically analyze data is
essential, as is competency with quantitative methods and statistical analysis.
We want to ensure that our trainees can work effectively in diverse groups and are skilled at communicating
with a variety of audiences. In addition to coursework and a deep immersion in a research laboratory, our trainees
will participate in two (out of four) enrichment tracks focused on Communication, Community Engagement and
Advocacy, Education, and Innovation and Entrepreneurship. In the Communication track, students will have the
opportunity to hone their skills in written, verbal and graphic presentations for expert, non-expert and lay
audiences. In the Community Engagement and Advocacy track, trainees will work with students in nearby
elementary schools, children's museums and city-wide events to foster their enthusiasm for, and appreciation
of, science. Engagement in science policy and advocacy in regional and national contexts will also be featured.
Trainees participating in the Education track will be educated in “teaching techniques”, will participate in teaching
externships at local universities and give guest lectures at regional HBCUs. Trainees in the Innovation and
Entrepreneurship track will earn a certificate by taking an online course and participating in local and regional
pitch competitions, and will participate in brief externships in local biotechnology companies and the MUSC
Foundation for Research Development. For at least two of these tracks, Digital Badges will also be offered.
As they pursue their dissertation research, our studies will participate in a variety of career development
activities that introduce them to a breadth of future opportunities within and beyond academe. They will be truly
prepared to make important contributions within the changing landscape of contemporary biomedical science.

Public health relevance
Central to our new training program is the commitment to educate a diverse population of students to think critically, conduct science in a rigorous, reproducible and ethical manner, work effectively in interdisciplinary teams, and communicate with a variety of audiences. In addition to coursework and a deep immersion in a research laboratory, our trainees will participate in a choice of enrichment tracks focused on Communication, Community Engagement and Advocacy, Education, and Innovation and Entrepreneurship. Our students will be prepared to make important contributions within the changing landscape of contemporary biomedical science.